Regulation of proliferation and differentiation in the male germ line adult stem cell lineage

Project Summary / Abstract
Our research is aimed at understanding the molecular mechanisms that regulate proliferation and differentiation
in adult stem cell lineages. These events are of crucial importance for both short and long term health, as adult
stem cell lineages underlie continued replacement of high turn over cell types in blood, skin, and the epithelial
lining of the gut, as well as maintenance and repair of many other tissues in the body. Our primary focus is on
elucidating the molecular circuitry that regulates the switch from precursor cell proliferation of onset of lineage
appropriate differentiation. Failure to cleanly switch from proliferation to differentiation may underlie genesis of
cancer in stem cell lineages, while failure to establish cell type specific gene expression for the proper
differentiation program may lead to dysgenesis, scarring, fibrosis, or tissue degeneration. We utilize
spermatogenesis in Drosophila as a model adult stem cell lineage in which the switch from proliferation to
differentiation is especially amenable to study in vivo using an integrated combination of powerful genetic,
genomic, cytological and biochemical tools. During spermatogenesis, mitotically proliferating spermatogonia
switch to onset of meiotic prophase, during which spermatocytes express hundreds of novel transcripts required
to regulate and mediate the dramatic changes in cell behavior and morphogenesis that eventually produce
mature sperm. Our goal under the MIRA is an integrated, systems level understanding of how the different
molecular mechanisms we have uncovered act in a pathway to trigger a clean switch from precursor cell
proliferation, establish a stable program of cell type-specific gene expression, and regulate its execution to time
and drive key steps in differentiation. Our approach will build upon recent technical advances and new
discoveries made in the current funding period. Springing from our discovery that the key role of the RNA binding
protein Bam required to trigger the switch from mitosis to meiosis is to repress expression of the nuclear RNA
binding protein How, we will identify RNAs bound by How by immunoprecipitation, score for alternative splicing
events that change immediately after How protein disappears from spermatogonia, and assess function of
candidate How targets in vivo, for example, whether they modulate expression of cell cycle regulators or bind to
promoters of differentiation genes as potential transcriptional regulators. Based on our finding that cell type
specific isoforms of RNA binding proteins expressed in the first wave of spermatocyte transcription modulate
alternative splicing, stability or translation of selected mRNAs expressed in the second wave, we will investigate
how early onset RNA binding proteins regulate timing and execution of the meiotic cell cycle and cell type specific
post meiotic cellular differentiation. Exploiting our genome wide, stage specific transcriptomic analysis, we will
work upstream from the earliest promoters that turn on in young spermatocytes to explore potential transcription
factors, chromatin regulators and nuclear architecture that may link onset of the gene expression program for
terminal differentiation with action of How to stop mitotic proliferation and trigger onset of the meiotic program.

Public health relevance
Project Narrative The proposed studies seek an integrated, systems level understanding of how multiple molecular mechanisms collaborate to control the critical biological switch from proliferation to differentiation, a key regulatory point in the adult stem cell lineages that underlie tissue maintenance and repair. Failure to cleanly execute this switch and halt proliferation may contribute to the genesis of cancer, while failure to correctly turn on cell type specific differentiation programs may underlie scarring, tissue degeneration, and aging. Our results will reveal how cell type and stage specific alternative mRNA processing, translational control, chromatin architecture, and transcriptional regulators act together to ensure that proliferation of precursor cells ceases and the correct gene expression program for differentiation of the right specialized cell type is turned on.